Novel Mechanisms of Regulation of SK channels: Implications for Cardiac Arrhythmia

Abstract
Small conductance Ca2+-activated K+ (SK) channels are present in sarcolemma (sSK) and inner mitochondria
membrane (IMM, mSK) in ventricular cardiomyocytes (VCMs). They have a unique ability to link intracellular
[Ca2+] with both plasmamembrane repolarization and mitochondria function. SK channels, although thought to
be dormant in health, are implicated in ventricular arrhythmias in animal models and in human patients with
heart failure (HF). Heterogeneous upregulation of SK channels can exacerbate substrate for arrhythmia.
However, recently accumulated evidence suggests that in HF or Long QT syndrome, SK channels provide
protection by mitigating loss of repolarization reserve and by reducing Ca2+-dependent triggers for arrhythmia.
The potential of SK channels as a target for anti-arrhythmic therapy is yet to be determined largely because of
the lack of understanding of cellular and molecular mechanisms that govern SK function. Our main objective is
to unravel mechanisms of regulation of sSK and mSK channels using rat model of hypertrophy and failure
induced by thoracic aortic banding (TAB). Our central hypothesis is that both sSKs and mSKs are positively
regulated by the serine-threonine kinase PKA and negatively regulated by the Tyrosine kinase Pyk2 via
modulating channel responsiveness to Ca2+/voltage-dependent block. We posit that PKA-mediated functional
upregulation of sSKs and mSKs plays an adaptive role by attenuating arrhythmic potential in hypertrophic
hearts, but that the protection offered is not complete. We therefore reason that further enhancement of sSK
and/or mSK activity can be achieved via inhibition of Pyk2-mediated phosphorylation, and that this could serve
as a novel approach to decrease arrhythmias in cardiac diseases associated with reduced repolarization
reserve and defective Ca2+ homeostasis such as hypertrophy and HF.
The Specific Aims are: 1: To determine the mechanisms of functional upregulation of sSKs in VCMs using a
TAB rat model of hypertrophy and HF. 2: To determine the mechanisms of mSK upregulation and their role in
regulation of RyR2-mediated Ca2+ release in TAB rat VCMs. We hypothesize that mSK upregulation facilitates
mitochondria cristae flattening which leads to increase in formation of tertiary supercomplexes (SCs) from
elements of Electron Transport Chain (ETC), thereby enhancing ETC efficiency and reducing rate of mito-ROS
production resulting in improvement in intracellular Ca2+ homeostasis. At the whole heart level, arrhythmogenic
effects of genetic enhancement or inhibition of SK channels will be studied using optical mapping of membrane
potential and Ca2+; at the single cell level, myocytes from TAB hearts will be investigated with a combination of
patch clamp, confocal microscopic imaging of Ca2+ and ROS using novel subcellular-compartmental
biosensors, mitochondrial membrane potential and currents, advanced electron tomography and biochemical
approaches. Cardiac-specific delivery with Adeno-associated viral vectors will be used to modify expression
levels and targeting of SK channels in TAB hearts.

Public health relevance
Project Narrative Small conductance calcium-dependent potassium (SK) channels have been implicated in cardiac pathology including atrial fibrillation and heart failure (HF). SK channels are thought to have a significant therapeutic potential due to their ability to couple cardiac excitation and intracellular calcium dynamics. These studies into modulation of heart function by SK channels should contribute important insights into mechanisms of arrhythmia and contractile dysfunction associated with acquired and genetic cardiac disorders and assist in development of novel SK-based therapeutic strategies for HF, Long QT Syndrome, and diabetes-associated cardiomyopathy.